Physiology of Respiratory Muscle Cells

DESCRIPTION (provided by applicant): Tumor necrosis factor-alpha (TNF-alpha) is suggested to promote atrophy and weakness of respiratory and limb skeletal muscles in diseases that range from chronic obstructive pulmonary disease to cancer, from congestive heart failure to AIDS. Despite its putative pathophysiological significance, surprisingly little is known about the mechanisms of TNF-alpha action in skeletal muscle. The long-term goal of this project is to determine the redox mechanisms by which TNF-alpha compromises muscle performance. Thus far, we have established that clinically-relevant levels of TNF-alpha act directly on skeletal muscle cells to stimulate loss of muscle protein without inducing apoptotic or necrotic cell death. Early signaling events in this catabolic response include activation of nuclear factor-kB (NFkB). Over several days, TNF-alpha/NFkB signaling accelerates degradation of muscle protein, causing a net protein loss. The current project extends our work on this pathway to address the underlying signaling events in greater depth and to evaluate the mechanism of accelerated protein degradation. We have three Specific Aims: 1.) To define receptor-mediated signaling events by which TNF-alpha activates NFkB in skeletal muscle. 2.) To evaluate regulation of ubiquitin conjugating activity by TNF-alpha. 3.) To evaluate the ubiquitin conjugating enzyme UbcH2 as an essential element of TNF-alpha/NFkB-regulated catabolism. These aims will be addressed using an integrative approach that incorporates muscle preparations ranging from cultured myotubes to TNF-alpha treated animals. Cause/effect relationships will be evaluated using a panel of pharmacologic, immunologic, and genetic interventions. Results of the proposed studies will help establish molecular mechanisms whereby TNFalpha stimulates catabolism of respiratory and limb skeletal muscle.